Examining feasibility, acceptability, and sustainability of a novel personalized smartphone intervention for suicide.

PROJECT SUMMARY/ABSTRACT
Suicide is a serious public health concern in the United States. However, despite an increase in theoretical
models of and treatments for suicide, the suicide rate has risen 33% since 1999. Given the widespread
availability of smartphone technology, there is great potential to deliver interventions via mobile platforms.
However, despite the proliferation of smartphone tools for suicide, few offer evidence-based support and some
include potentially harmful content. In response, we have conducted initial development of a mobile suicide
prevention system: Mobile Application to Prevent Suicide (MAPS). MAPS was specifically designed to identify
increased suicide risk and deliver personalized intervention for patients transitioning out of a psychiatric hospital,
a time of extraordinarily high risk. MAPS provides both a mobile app and clinician support, and includes multiple
evidence-based components: (1) monitoring of thoughts, emotions, and behaviors via ecological momentary
assessment (EMA), (2) personalized, interactive coping strategy administration based on participants’ current
risk state, (3) direct access to clinicians and crisis support services, and (4) psychoeducation. We will leverage
existing components of MAPS and develop and test new features. To plan for sustainability of MAPS, we will
deliver the intervention through the Butler Hospital Transitional Outpatient Program, assigning participants to
master’s level hospital clinicians, and convene a Stakeholder Advisory Board with a focus on program
sustainability. Specifically, the primary aim of this investigation is to establish feasibility, acceptability, safety, and
estimate key parameters for primary outcomes (i.e., suicidal ideation and behavior; re-hospitalization), and target
mechanisms (i.e., self-monitoring, use of coping strategies, reduction of negative affect, self-efficacy). The
ultimate goal of this project is to further develop and refine the MAPS system and engage in preliminary testing
in preparation for a fully-powered randomized clinical trial (R01) to establish effectiveness of the intervention in
a larger health care system and to further optimize intervention components and delivery (e.g., machine learning
techniques). This proposal outlines procedures for intervention and clinician training program refinement through
focus groups and open and randomized pilot trials. Thus, the present study is designed to develop the tools,
procedures, and knowledge base for a novel intervention.

Public health relevance
PROJECT NARRATIVE Suicide is a major public health problem, with over 47,000 deaths by suicide per year, and individuals discharged from psychiatric hospitals are at extraordinarily elevated risk for suicide. Currently available treatments for suicide have not led to a decrease in the suicide rate. The primary aim of the present study is leverage existing infrastructure to develop novel technological features for a novel personalized smartphone intervention system, and to establish feasibility, acceptability, safety, and estimate key parameters for primary outcomes (i.e., suicidal ideation and behavior; re-hospitalization), and target mechanisms.